Reprogramming the TME for immunogenic antigen-presentation

One of the missing high-impact opportunities in immuno-oncology has been the inability to maximally exploit the
synergy between conventional chemotherapy and novel immunotherapy. The premise of the current proposal
is that successful chemo-immunotherapy critically depends on eliciting robustly immunogenic, pro-inflammatory
antigen-presenting cells that can cross-present tumor antigens. In tumors at baseline, however, the cross-
presenting dendritic cell (DC) population is profoundly defective, and the default immune response is tolerance
and immunosuppression. How to change this defect has been unclear. This proposal tests the hypothesis
that Bruton’s Tyrosine Kinase (BTK) in tumor-associate myeloid cells represents a powerful and previously
unrecognized innate-immune system checkpoint, that dominantly suppresses the emergence of a key population
of highly pro-inflammatory monocyte-lineage DCs during chemotherapy. If the suppression by this myeloid BTK
checkpoint can be overcome, then dying tumor cells now become able to spontaneously elicit large numbers of
inflammatory monocytic DCs, which drive robust and sustained anti-tumor immunity. Aim 1 will use genetically-
defined models to identify the specific myeloid-lineage cells in tumors that are suppressed by BTK. It will test
the hypothesis that when the BTK checkpoint is blocked during chemotherapy, these immature myeloid cells
now become able to rapidly mature into inflammatory DCs. These activated DCs reprogram the “cold” tumor
milieu into a “hot” pro-inflammatory microenvironment, and re-activate anergic CD8+ effector T cells. Aim 2 will
test the hypothesis that the BTK checkpoint is normally dominant in tumors, because it is constantly driven by
key tolerogenic signals such as tumor-induced Tregs and local TGFβ. However, if this repressive BTK pathway
is blocked, then immature myeloid cells in tumors become able to mature into inflammatory APCs in response
to signals from dying tumor cells. Aim 3 will test the hypothesis that the tolerogenic indoleamine 2,3-
dioxygenase (IDO) pathway is tightly coupled to the BTK checkpoint in myeloid cells. During chemotherapy,
IDO acts as a direct cell-intrinsic metabolic signaling pathway downstream of BTK, allowing BTK to suppress the
maturation-inducing mTOR pathway in DCs. IDO is also elicited by dying tumor cells during chemotherapy as a
paracrine pathway in plasmacytoid DCs and tumor-associated macrophages, which activate Tregs and produce
local TGFβ to reinforces the BTK checkpoint. Thus, blocking both BTK and IDO together creates potent
mechanistic synergy, and allows robust anti-tumor immune activation during even modest chemotherapy.
Relevance: If the proposed strategies are successful, this will bring a novel, high-impact approach to
chemo-immunotherapy, focused on eliciting a crucial population of immunogenic antigen-presenting cells. BTK-
inhibitor drugs are approved, and IDO-inhibitor drugs are in clinical trials, so translation to the clinic would be
rapid and direct.

Public health relevance
Approaches that could combine standard chemotherapy agents with targeted immunotherapy for the treatment of cancer have the potential for high clinical impact, but it has been difficult to identify synergistic combinations. The current proposal identifies Bruton’s Tyroseine Kinase (BTK), expressed in specialized host antigen- presenting cells, as a previously unsuspected pathway that suppresses immune responses following chemotherapy. BTK-inhibitor drugs are already in use for other indications, so re-purposing these agents as part of a multi-modal chemo-immunotherapy approach is highly translatable to the clinic.